Biogenesis of hERG1a/1b ion channels in health and disease model cardiomyocytes

ABSTRACT/SUMMARY
Cardiac IKr is a critical repolarizing potassium current shaping the human ventricular action potential. It is
conducted by heteromeric assemblies of the human ether-à-go-go-related gene (hERG1) 1a and 1b subunits.
These subunits are encoded by alternate transcripts of the hERG/KCNH2 gene and differ only in their amino-
terminal regions. hERG1a/1b heteromerization is vital for normal CM function, as the imbalance of subunit
expression and/or function results in cellular pro-arrhythmic behaviors. hERG1a/1b assembly is mediated by
the co-translational association of the encoding mRNAs in HEK293 cells, cardiomyocytes derived from human
induced pluripotent stem cells (hiPSC-CMs), and human myocardium. Evidence suggests that interaction
between the nascent proteins is not required for the co-translational complex assembly. This grant's
preliminary findings indicate that this complex assembly occurs post-transcriptionally and is promoted by direct
interactions between hERG1a and 1b mRNAs governed by their secondary structures. In preliminary studies,
RNA binding proteins DDX3X and DDX5 were identified as part of the complex, and purified DDX3X promoted
hERG1a/1b mRNAs' association in vitro. In the K99 phase, I will define the mRNA structural features
promoting the co-translational association and determine the affinity and energies of the RNA/RNA interaction
using in vitro systems, isothermal calorimetry (ITC), mutagenesis, hybrid protein-RNA immunoprecipitation
(RIP), and live-cell imaging. I will also determine whether DDX3X and DDX5 affect hERG1a and 1b mRNAs
stability, translation, and association in hiPSC-CMs using qPCR, electrophysiology, Western Blot, ribosome
profiling, RIP, and single molecule fluorescent in situ hybridization (smFISH). I will use quantitative ITC and in
vitro reconstitution approaches to determine the specificity, affinity, and energies of the interaction between
purified DDX3X and DDX5 with hERG1a and 1b mRNAs. I will also evaluate if DDX3X and DDX5 promote the
association of the mRNAs in in vitro systems. In the R00 phase, I will determine whether the stability,
translation, and association of hERG1a and 1b mRNAs are impaired in arrhythmias associated with type 2 long
QT syndrome (LQT2). I will use hiPSC-CM disease models to evaluate half-life, translation rate, and
association of the mRNAs with qPCR, ribosome profiling, RIP, and smFISH. These experiments will contribute
to understanding ion channel biogenesis and elucidate molecular mechanisms underlying LQT2 related
arrhythmias. This proposal is designed to fulfill my short-term goals of expanding my skills in cardiovascular
research and biophysics and transitioning into the independent phase of my career. This will ultimately allow
me to obtain my long-term purpose of linking RNA and ion channel biophysics to translational cardiovascular
research.

Public health relevance
NARRATIVE Disease of the heart is the leading cause of death in the United States. The proposed research will help us better understand how a protein contributing to proper heart rhythm is produced in cardiac cells, while defects in its formation can lead to abnormal heart beating and sudden death.